Smart Foot Mat

Smart Foot Mat Abstract
Eden Medical is pleased to develop the Smart Foot Mat (SfM), as a simple in-home appliance for
stopping diabetic foot complications. We propose a powerful game-changing strategy having
diabetics step on their smart mat at home once a day to monitor their foot oximetry and
temperature over time to alert them early signs of ulcer onset. Near infrared spectroscopy (NIRS)
biomarkers provide a quantitative ulcer risk metric and can used to predict diabetic foot onset.
Complications of diabetes that affect the lower extremities are common, complex, and costly.
Diabetes is the most common metabolic disease worldwide with global cost of diabetes
management including foot ulceration is now $825 billion dollars every year. Foot ulceration is
the most frequently recognized complication with 537 million adults who live with diabetes
globally and it predicted to rise to 643 million by 2030. Recent investigations suggest that 40%
of patients experience a recurrent diabetic foot ulcer (DFU) in the year after healing, and almost
60% within 3 years. Daily in-home monitoring will provide ulcer-free living for high-risk
diabetic patients.

Public health relevance
Smart Foot Mat Narrative Complications of diabetes that affect the lower extremities are common, complex, and costly. Foot ulceration is the most frequently recognized complication. Recent investigations suggest that 40% of patients experience a recurrent diabetic foot ulcer in the year after healing, and almost 60% within 3 years. Eden Medical is developing a smart foot mat platform to perform daily inspection of their feet to predict ulcer onset and reduce the risk of lower extremity amputation.